MASS SPECRTOMETRY

The proposed MS system will aid in the following areas of organic and biological chemistry. 1. Synthesis of bioactive natural products. 2. Synthesis and study of molecular recognition substrates. 3. Peptide and glycopeptide synthesis and conformational studies. 4. Oligonucleotide Chemistry. 5.Chemical modification of proteins and oligonucleotides by carcinogens and chemotherapeutic drugs. 6.Enzyme mechanism.